Effects of Platelet Transfusions on Neonatal Chronic Lung Disease and Sepsis-Induced Mortality

SUMMARY
This K99/R00 proposal describes a five-year mentored research and training plan that will facilitate the transition
of Dr. Patricia Davenport to an independent academic researcher in neonatal hematology. Dr. Davenport is a
productive and dedicated young physician-scientist working in a clinically relevant and understudied field. PLTs
are active participants in both hemostasis and inflammation, yet clinical awareness of these dual roles has lagged
behind research discoveries, particularly in neonatology. Preterm infants are at high risk of spontaneous bleeding
(particularly intracranial) and thus are typically transfused at higher PLT counts than children or adults, in the
hope of preventing bleeding. However, a recent large randomized trial in preterm neonates found that liberal
PLT transfusions increased mortality and risk of chronic lung disease, without decreasing bleeding. The
mechanisms mediating these findings are unknown, but we hypothesize that they are at least partly related to
the developmental differences between neonatal and adult PLTs. The overarching aim of this proposal is to
improve the management of neonatal thrombocytopenia through a better understanding of the consequences of
PLT transfusions in neonates with various underlying pathologies. Our overall hypothesis is that the effects of
PLT transfusions increasing neonatal mortality and severity of chronic lung disease are mediated by an
amplification of the neonatal inflammatory responses. To test this hypothesis, we designed the following Specific
Aims: 1. Determine the effects of PLT transfusions on newborn mice with and without endotoxemia; 2. Determine
the effects of PLT transfusions on mortality in a neonatal model of sepsis; and 3. Characterize the effects of PLT
transfusions in a neonatal murine model of chronic lung disease. This research is highly significant, as knowledge
gained from it will inform clinical practice and research. Dr. Davenport will receive mentorship from her co-
mentors, Dr. Martha Sola-Visner, an NIH-funded researcher in the field of neonatal PLT biology, and Dr. Stella
Kourembanas, a world-renowned investigator in neonatal pulmonary physiology and chronic lung disease. In
addition, Dr. Davenport will have the guidance of her Scientific Advisory Committee, composed of distinguished
scientists with expertise in transfusion medicine and immunology, neonatal sepsis and inflammation, infectious
diseases, and study design/statistics. The training opportunities and resources at Boston Children’s Hospital
(BCH) and Harvard Medical School provide an ideal environment for the candidate’s career development. The
Division of Newborn Medicine at BCH is committed to Dr. Davenport’s success and has assured at least 75%
protected time to devote to the activities described in this proposal. A detailed career development and training
plan is presented, including mentored research, didactic coursework, seminars and presentations at scientific
meetings, and a plan for manuscript writing and R00 submission. The expertise and knowledge gained from this
Award will enable Dr. Davenport to obtain future R01 funding and transition to an independent research career
focusing on neonatal PLT biology, and particularly the interactions of PLTs with the neonatal lung.

Public health relevance
PROJECT NARRATIVE Platelets are small blood cells that participate in clot formation to stop bleeding and also in the response to inflammation, although only their clot forming abilities are considered when administering platelet transfusions to premature babies, who often receive platelet transfusions in hopes of decreasing their bleeding risk. Premature babies are a vulnerable population with high morbidity and mortality due to multiple disease processes, and a recent large study found that babies who received more platelet transfusions had a higher mortality and risk of lung disease than babies who were transfused less. In this project I will investigate the effects of platelet transfusions in models of neonatal infection and lung disease and the mechanisms through which platelet transfusions increase neonatal mortality and lung injury, with the hope of improving the outcomes of these most vulnerable patients.